Technical Development Unit 2: Intelligent Hyperspectral Imaging of Subcellular Molecular States at the Whole Organ Level

PROJECT SUMMARY/ABSTRACT
Cancers of different types preferentially metastasize to different tissues and specific sites in these tissues. Why
this is true remains poorly understood but is likely to involve a combination of cell intrinsic factors (e.g., the
ability of a cell to survive differences in mitogenic factors, nutrient availability, or context-specific stressors) and
extrinsic effects (tissue-specific mechanical and biochemical cues). Gaining molecular insight into events
involved in metastatic colonization is challenging, because such events are rare, colonies are initially small,
and potential sites of colonization are widely distributed. The focus of this TDU is the development, validation
and dissemination of innovative toolkits for deep multiplexed tissue imaging; these toolkits will be developed in
close association with our RTBs and provided to the wider CCBIR consortium. When mature, the methods we
described will enable quantitative measurement of molecular processes involving ~60 proteins or other
biomolecules at subcellular resolution in a preserved tissue context. In Aim 1 we will assemble a self-driving
multiscale microscope that leverages advances in tissue clearing, fully automated high-speed and high-
resolution light-sheet fluorescence imaging, and computer vision, to identify the earliest events in metastasis,
including the colonization of a tissue by a single metastatic cell. This microscope will have mesoscopic and
nanoscopic imaging modes. The mesoscopic module has computationally controlled magnification (0.63X to
6.3X) and provides ~5-10 µm isotropic resolution throughout a 2.1-21mm field of view. The nanoscopic module
provides ~330nm isotropic resolution throughout a 300 µm field of view. Biological features (metastatic
colonies) will be rapidly and efficiently identified with the mesoscopic module and interrogated at high
resolution using the nanoscopic module. Aim 2 will involve development of physically and chemically
accelerated 60-plex cyclic immunofluorescence assays of tissue sections thick enough(~200 µm) to fully
encompass a metastatic colony and its tissue niche. Thick section highly multiplexed and high-resolution
imaging will then be combined with CRISPR-Cas9 engineered cell lines from the RTBs to test specific
hypotheses about signaling, differentiation, and morphological mechanisms involved in metastasis. Support for
spatial transcript profiling and tissue proteomics will aid with integration into more gnomically focused NCI
programs. Aim 3 will develop a fully automated multi-technology microscope able to accurately describe
metastatic heterogeneity in a statistically robust fashion. The instrument will combine deep isotropic resolution
imaging with highly multiplexed methods via automated sample handling, labeling, imaging and analysis. This
next-generation microscope will involve several generalizable technologies for comprehensively profiling rare
events in metastasis and also cancer initiation, which is another rare event. Together, the approaches we
describe are expected to substantially advance our understanding of one of the least characterized and most
lethal features of solid tumors.